Contralaterally Controlled FES Combined with Brain Stimulation for Severe Upper limb Hemiplegia

PROJECT SUMMARY/ABSTRACT
Development of rehabilitation interventions that are both effective and appropriate for patients with severe
upper limb paresis remains a major unmet clinical need. These patients have little to no volitional movement
and therefore are left with a non-functional upper limb. Many rehabilitation therapies are inappropriate for this
sub-population because they require significant residual movement. We have developed and tested a new
therapy that can be delivered in patients with little to no residual hand/finger motion. Known as contralaterally
controlled functional electrical stimulation (CCFES), the technique applies neuromuscular electrical stimulation
(NMES) to paretic wrist, finger, and thumb extensors to produce hand opening. The patient controls the
intensity of stimulation by wearing a glove with sensors on their unaffected contralateral hand. When the
patient opens their unaffected hand, a proportional intensity of stimulation opens their paretic hand. Therefore,
no residual movement of the paretic hand is necessary, which allows even patients with severe paresis to
engage in functional task practice using the affected upper limb. We have shown in a recent RCT that CCFES
is more effective than conventional NMES at reducing upper limb motor impairment in severe patients. But
patients continue to experience limitation in functional abilities. The goal of this study is to build upon the gains
achieved with CCFES in severe patients by augmenting its effects with another technique we have shown to
facilitate improvements in this sub-population. Non-invasive brain stimulation delivered to facilitate the intact
contralesional higher-motor cortices (cHMC) can have positive effects on upper limb motor control in severe
patients. When extensive damage to ipsilesional corticospinal pathways renders the damaged ipsilesional
primary motor cortex (iM1) ineffective at controlling paretic limb movement, intact, contralesional motor cortices
especially the cHMC can contribute by changing the balance of interhemispheric inhibition between motor
cortices and by increasing the excitability of uncrossed projections from the contralesional cortex to the paretic
upper limb. Therefore, here, we will test the scientific premise that CCFES augmented with facilitation of cHMC
will lead to greater upper limb motor improvement in severe patients than CCFES augmented with
conventional facilitation of iM1 or than CCFES alone. Seventy-two patients with severe hand impairment will
receive 12 weeks of CCFES + cHMC facilitation, CCFES + iM1 facilitation, or CCFES + sham brain
stimulation. Assessments of upper limb motor function and neurophysiology will be completed at baseline, 6,
12, 24, and 36 weeks. This study will 1) determine whether cHMC facilitation augments the effects of CCFES
to produce greater improvements in upper limb function in severe patients, 2) investigate the underlying
neurophysiologic mechanisms contributing to restored paretic limb motor control, and 3) evaluate and identify
patient factors that affect efficacy of CCFES + cHMC facilitation.
!

Public health relevance
PROJECT NARRATIVE There are an estimated 7 million stroke survivors living in the United States. More than two-thirds of these have residual paralysis of the upper limb, and of them, ~37%-50% have severe paralysis. There are few treatment options that are appropriate or effective for patients with severe paresis. Here, we will test whether the combination of a unique rehabilitation therapy that is easy to administer in patients with little to residual motion and a new brain stimulation technique that taps into intact neural resources would produce higher gains in upper limb function than those that can be achieved with conventional treatment in patients with severe paralysis. ! !